HIV Latency Reversal Through Novel, Potent PKC Modulators

ABSTRACT Although anti-retroviral therapy (ART) slows disease progression, ART is a life-long therapy, which requires strict medical compliance to avoid viral resistance and is associated with significant costs and long-term medically adverse effects. In addition, ART is not curative because it does not eliminate reservoirs of replication-competent virus. Thus, if ART is discontinued, HIV can emerge from reservoirs and rapidly spread, leading to disease progression towards AIDS. One potential strategy for clearing these reservoirs of latently infected cells is to use a kick and kill approach, in which latent cells are “kicked” or activated from latency, allowing their subsequent “killing” by viral cytopathic effects, immune effector cells or additional therapies targeted at HIV-infected cells. Latency reversing agents (LRA) have been used to “kick” or induce HIV expression from latent cells, but thus far have been limited by suboptimal efficacy, drug toxicity, and/or biodistribution issues. In this renewal application, we address these problems using a new LRA concept to improve efficacy and tolerability and control biodistribution. We investigate protein kinase C (PKC) modulators, which are the most potent and efficacious LRAs, focusing particularly on the best-performers - bryostatin-1, prostratin and ingenol esters and potentially new LRAs of the ingenane and tigliane families. We have found that the chemical conversion of bryostatin-1 into a prodrug (slow-release) version results in a novel LRA with superior activity and improved tolerability. Thus, the goal of this renewal application is to advance the study of this new concept and new class of chemically synthesized prodrug LRAs using a highly collaborative team with expertise in novel computer-based design, synthesis, medicinal chemistry, state-of-the-art in vitro assays, and sophisticated in vivo animal modeling. Optimal prodrug LRAs will be used in conjunction with a “kill” approach (natural killer cells) in humanized mice latently infected with HIV to assess the efficacy of the kick and kill approach. We will accomplish our goals through the following Specific Aims: 1) Evaluate in vitro and in vivo a new concept for latency reversal based on new LRA prodrugs, 2) Define the specific PKC isoforms and non-PKC pathways that contribute to HIV latency reversal, and 3) Investigate synergies of new and known LRAs that enhance HIV reservoir depletion. Collectively these studies will advance our unique and superior preclinical LRAs towards clinical testing and provide information critically needed for implementation of kick and kill approaches for HIV eradication.

Public health relevance
PROJECT NARRATIVE Although antiretroviral drugs can suppress HIV infection, these drugs do not eliminate latently infected cells that resupply active virus and thus require life-long administration with cost, compliance, resistance and chemo- exposure concerns. Combining computer-based design, synthesis, medicinal chemistry and state-of-the-art in vitro and in vivo modeling, the proposed studies will evaluate a new concept and new compounds for reversing HIV latency including conceptually new prodrug latency reversing agents (LRAs) representing the most effective and best tolerated LRAs thus far, determine mechanistic requirements for their LRA activation using PKC inhibitors and transcriptomic analyses, determine synergies and tolerabilities between our new and known LRAs, and test the best performing LRAs or LRA combinations in a kick and kill strategy, collectively serving as a preclinical prelude for HIV eradication and clinical evaluation.